Skeletal Biology and Biomechanics (SBB) Core

SUMMARY
The UCSF Core Center for Musculoskeletal Biology and Medicine Skeletal Biology and Biomechanics (SBB)
Core supports a large and robust research base of investigators. This diverse group of basic and clinical
investigators has made major contributions to the understanding of musculoskeletal health and disease.
However, the ongoing research efforts by these and other investigators remain insufficient to prevent the rapidly
increasing occurrence of many acquired musculoskeletal diseases in our aging population. Thus, acceleration
of research that advances the prevention and treatment of skeletal diseases is urgently needed. Solutions will
require a more systems-based approach with integrated research strategies and investigator communities. To
meet this challenge, the SBB Core facilitates musculoskeletal research at UCSF by providing integrated, cost
effective, and efficient access to rigorous musculoskeletal biology and biomechanics services. The SBB Core
serves and cultivates the musculoskeletal research community across multiple campuses and disciplines by
offering users seamless access to services, with Core sites at the two main UCSF campuses, easy digital
conferencing, and events at multiple locations. The successful implementation of the SBB Core is anticipated to
not only reduce research expenses and increase data output, rigor, and reproducibility, but also to produce
robust in-depth analyses of human samples and animal models through integration of different aspects of
musculoskeletal biology and biomechanics. The Core’s adoption of sophisticated and powerful large-scale
ensemble as well as spatially defined, cell-specific transcriptomic and proteomic profiling will streamline
quantitative analyses of musculoskeletal tissues to complement and encourage the much-needed application of
big data approaches to this field. Through training and education, the SBB Core will continue to promote the
entry of new investigators to the field, and it will foster a community of versatile musculoskeletal researchers with
a broad set of skills and critical thinking.

Public health relevance
PROJECT NARRATIVE Not Applicable